The role of the nucleolus in human genome organization in normal and disease states

7. Project Summary / Abstract
In all eukaryotes, the largest nuclear body is the nucleolus, a phase-separated, non-membrane bound
organelle specialized for the synthesis of ribosomal RNAs and their assembly into ribosomes. Additionally, the
exterior of the nucleolus is a hub for interactions with multiple specific DNA loci, thereby contributing to the
three-dimensional architecture of the eukaryotic nucleus.
Nucleolus-genome interactions are intimately connected to processes central to human health. For
example, nucleolar-associated DNA is highly enriched in centromeric repetitive sequences. Centromeres, the
sites of chromosome attachment to mitotic spindles, are fundamentally important for proper chromosome
segregation. Several nucleolar proteins have been implicated in centromere-nucleolar interactions, and several
centromeric proteins prominently reside in nucleoli in interphase cells. We have found that the nucleolar-
centromeric interactions are regulated during cellular differentiation and are greatly increased in cancer cells.
However, the mechanisms that regulated these interactions remain unknown.
Not only do cancer cells display increased centromere-nucleolar interactions, they also frequently contain a
perinucleolar compartments (PNC), a complex cytological feature that is absent in non-tumor cells. PNCs are
located on the surface of nucleoli and contain multiple RNA species and RNA-binding proteins. We
demonstrate here that these bodies also contain specific DNA loci, some of which encode non-coding RNAs
retained within PNCs. A candidate cancer therapeutic termed metarrestin was isolated based on its ability to
dissociate PNCs; metarrestin is currently in clinical trials based on its ability to reduce metastasis in human
tumor xenograft experiments. Importantly for this proposal, we have observed that metarrestin also perturbs
centromere-nucleolar interactions.
We also present data that centromere-nucleolus interactions are perturbed in macrophages upon exposure
the bacterial lipopolysaccharide (LPS), a canonical stimulus for the innate immune system. We also show that
this response is blocked upon inhibition of specific signaling pathways. These changes are accompanied by
altered nuclear distribution of the H3K27me3, a histone modification characteristic of facultative
heterochromatin.
Altogether, the central theme of this proposal is that the factors that govern centromere-nucleolus
interactions are important for understanding chromosome missegregation, metastasis, and innate immunity.
We plan a series of synergistic experiments to learn more about the underlying mechanisms. For example, we
will test whether the centromeric activity of neocentromeres generates nucleolar associations, or if instead that
is a property of centromeric satellite repeats regardless of activity. We will take candidate and unbiased
approaches to finding centromeric proteins required for nucleolar interactions. We will characterize how
metarrestin affects association of DNA loci with PNCs and nucleoli, and we will define cis-acting loci involved in
PNC association. We will characterize the signaling pathways required for signaling-mediated disruption of
nucleolar-centromeric interactions in macrophages. Results from these studies will allow for subsequent testing
of universality. For example, do signaling components in macrophages also operate in tumor cells when
treated with the therapeutic metarrestin? In this manner, this collaborative proposal will unite questions from
diverse experimental systems to answer questions about the fundamental links between nuclear organization
and human health.

Public health relevance
8. Project Narrative / Relevance. The nucleolus is not only the site of ribosome assembly, but also a dynamic genomic organization hub that recruits interactions with specific loci. We have found that several types of genomic interactions at the nucleolus surface are altered during events important for human health, including signaling of infections, differentiation processes, or during carcinogenesis and responses to anticancer treatment. We plan to use genome-scale methods to analyze how these interactions are altered, and to determine the mechanisms underlying these higher-order chromosome movements. These studies will provide invaluable tools and datasets for studying how human chromosomes respond to a variety of environmental stresses.